Engaging Impactful Immunotherapy Approaches in Renal Cell Cancer Studies

Summary
Dr. Naomi Haas is a genitourinary (GU) medical oncologist at the Abramson Cancer Center (ACC)
with expertise in writing and leading cooperative group, industry-led, and investigator-initiated
trials (IITs). She is the renal sub-committee chair within ECOG-ACRIN (EA) and co-leader of the
Cancer Therapeutics Program at the ACC. She requests support from this R50 award for
initiatives at the ACC (developing immunotherapy trials in renal cell cancer [RCC] to bring to the
NCTN) and within the NCTN. Participation in translational research has been a motive force for
her professional activities since she spent almost 5 years in a basic science laboratory after her
fellowship. As co-leader of Cancer Therapeutics, she connects clinicians with translational
scientists to leverage novel biomarker signals and immune signals into NCTN IITs. One example
is her ongoing work with A. Huang at the ACC in characterizing T cell subsets predictive of T cell
exhaustion after immune checkpoint inhibitor (ICI) therapy. A new collaboration with K. Alexander
will understand the role of chromatin condensation manifested by nuclear speckling in assessing
prognosis and response to ICI therapy in RCC. Incorporating both these molecular tools, she is
working with a young investigator (YI) and a urologist in launching a clinical trial in which patients
who achieve deep responses from ICI therapy undergo resection of residual disease
(consolidation) with the goal of treatment-free survival as a future NCTN trial. She also works
with C. June to build novel chimeric antigen receptor (CAR) T cells for use in RCC. With safety
data supporting that their CARs can be developed as multi-institutional trials, she is uniquely
positioned to supervise transition of such studies from single- to multi-institutional settings, a key
step in their availability to patients. Dr. Haas has two emerging roles within the NCTN: First, her
new appointment as the ECOG-ACRIN GU Committee Chair will allow her to define scientific
priorities with subcommittee chairs and mentor YIs. Second, from her experiences using biologic
specimens and clinical data from many NCTN trials, she has identified obstacles to full sample
sets for study patients. Working with the EA Research Advocate Committee to amend processes
at participating institutions, she has developed a plan to communicate correlative study goals to
patients and study staff. These changes should improve correlative data acquisition and patient
retention nationally. Thus, her R50 support will improve ACC and national NCTN participation by
building RCC immunotherapy platforms at ACC, by engaging YIs and urologists in future NCTN
projects, and by improving the correlative and patient retention process within the NCTN.

Public health relevance
Narrative Dr. Haas' R50 application requests support for protected time to build a collaborative translational and clinical immune therapy community focused on kidney cancer at the Abramson Cancer Center (ACC) that can bring trials to ECOG-ACRIN. In addition, she plans to improve retention of clinical and biologic data through NCTN processes. Her expertise in potentially curative novel cellular and immunotherapy for kidney cancer and her long-standing engagement in the NCTN uniquely position her to bring these approaches to the cooperative groups.